Osteocyte Mechanotransduction and the Gabapentin-Sensitive Matrix-Channel Tethering Complex

Project Summary
The skeleton relies on a variety of mechanical, biochemical, and hormonal cues to regulate bone strength,
structure, and mass. Osteocytes are both the most abundant and most mechanosensitive cells within bone.
Located deep in the bone matrix, these cells are optimally positioned to sense and respond to force, directing
the activity of other skeletal cells, including osteoblasts and osteoclasts. A variety of molecules influence
osteocyte mechanosensation; however, how force is directly transmitted from the mineralized matrix to the cell
membrane to induce a biological response remains unknown. We have identified the presence of a complex
within osteocytes composed of extracellular perlecan/HSPG2 and a cell surface subunit (a2d1) of voltage
sensitive calcium channels (VSCCs). As the perlecan-containing tethers bind the a2d1 subunit of VSCCs, this
Matrix-Channel Tethering Complex (M-CTC) enables direct connection between the mineralized matrix and the
cell membrane. Thus, the proposed studies will dissect how this mechanosensory complex mechanistically
regulates osteocyte behavior, under both basal and mechanical loading conditions. Additionally, the a2d1
subunit of the complex is the receptor for the commonly used antiepileptic and neuropathic pain drug,
gabapentin, which can have severe adverse skeletal side effects. Thus, this work will not only investigate the
foundational mechanisms through which osteocytes sense force, but will also inform the design of novel
strategies to offset the negative effects of gabapentin on bone that reduce bone mass.
Our overarching hypothesis is that perlecan-containing tethers, within the M-CTC, transmit force to the a2d1
subunit of VSCCs, enabling mechanical signals to be transduced into anabolic biochemical responses in
osteocytes.
Aim 1: Determine if osteocyte-specific disruption of the M-CTC membrane receptor a2d1 impairs basal
or load-induced bone formation with resultant loss in bone quality.
Aim 2: Determine if tissue-specific genetic ablation of the PLN matrix tethers within the M-CTC of
osteocytes impairs basal or load-induced bone formation with resultant loss in bone quality.
Aim 3: Determine how gabapentin interferes with the M-CTC to impair basal and load-induced bone
formation.
The function of the M-CTC has not been explored in vivo. As such, these integrated studies, designed to
genetically and pharmacologically disrupt the M-CTC and assess the functional consequences, will provide
basic insights into the relationship between extracellular tethers and calcium channels in bone. In the long
term, this understanding may reduce bone loss in patients treated with gabapentin for neuropathic pain.

Public health relevance
Project Narrative The skeleton is highly sensitive to mechanical force, where disuse or disease leads to bone loss, skeletal fracture and major morbidities; however, it remains unclear how bone cells sense and respond to mechanical stimuli, hampering efforts to design novel anabolic treatments. We found that the mineralized matrix of bone connects to calcium channels via an auxiliary subunit of voltage sensitive calcium channels, forming the matrix- channel tethering complex, where force is transmitted to cells. Using genetically modified mouse models, molecular/biochemistry techniques, and pharmacological approaches, we will determine the mechanisms by which each of the components of this complex influence bone formation, revealing methods to target these structures to enhance bone strength and prevent fractures.